The contribution of the hippocampus to learned opiate tolerance

Project Summary
The utility of opiates for treating pain is limited by the development of tolerance, a phenomenon that can lead to dose-
escalation and an increased liability for dangerous side effects like dependence and overdose. Interestingly,
environmental cues that are paired with opiates can dramatically influence tolerance. Specifically, animals that receive
morphine in a particular context exhibit analgesic tolerance that can be eliminated by simply administering the drug in a
new environment. The cellular and circuit mechanisms underlying this associative form of tolerance have not been well
characterized. However, they are highly relevant clinically as many overdoses occur when addicts take large amounts of
opiates in a new place. In this application, we propose to dissect the circuitry underlying associate morphine tolerance
using modern behavioral neuroscience tools. Specifically, we will combine optogenetic techniques with transgenic
reporter mice to identify the specific neural circuits and cells that mediate associative tolerance. Our central hypothesis
is that context-specific representations in the hippocampus become associated with opiate use and produce a
compensatory response in the amygdala that prevents the inhibition of pain. To test this idea, we will express light
sensitive opsins in the specific neurons that are active during the expression of associative morphine tolerance. We
predict that silencing these cells will prevent tolerance in a morphine-paired context. Stimulating these cells, in contrast,
should induce tolerance in a novel environment that has never been paired with morphine. A similar strategy has been
used to identify and manipulate neurons that encode fear memories in the amygdala, spatial memories in the
hippocampus, cocaine memories in the nucleus accumbens and many others forms of memory. However, to our
knowledge, this approach has never been applied to associative morphine tolerance. We believe that doing so will lead
to significant advances like it has for other forms of learning and memory.

Public health relevance
Project Narrative Addiction to opiate drugs is a major problem in the United States, costing an estimated $78 billion dollars and 27,000 lives lost per year. This problem is exacerbated by the fact that tolerance to opiates develops rapidly, leading to dose-escalation and an increased liability for dangerous side effects like dependence and overdose. Consequently, a major goal of addiction research is to understand the mechanisms that give rise to tolerance so that it can be prevented or reversed. The current application will examine the contribution that learning makes to opiate tolerance. It has been known since the 1970s that environmental cues can become associated with opiate drugs and reduce their efficacy (a.k.a. associative tolerance). This type of tolerance is unique in that it depends on associative learning and is modulated by contextual cues. We propose to use modern neuroscience tools in the current application to identify the specific cells and circuits that mediate associative morphine tolerance in the hippocampus and amygdala.